PRIHSM Training Component

Project Summary – Training Component
The goals of the Training Component are to: (1) develop a training program that cultivates a community of trainees focused on maternal health; (2) build content knowledge and expertise relevant to conducting multi-disciplinary research in prevention and treatment of postpartum hemorrhage (PPH) and related maternal morbidities and mortality; and (3) equip clinicians with skills important for the treatment of PPH. These goals will be accomplished by developing a multi-disciplinary team of trainees and mentors, implementing specific activities tailored to meet the needs of trainees with a wide variety of experiences and interests, and leveraging existing programs within Stanford. Postpartum hemorrhage is the thematic focus of PRIHSM and will be a unifying thread throughout training activities, which will also extend to the additional focus areas of our projects: severe maternal morbidity (SMM) and mortality, antepartum anemia, and cesarean birth. We will work with trainees at varied stages of training (e.g., undergraduate to early-stage investigator) and representing varied disciplines (e.g., clinical medicine, psychology, epidemiology, implementation science, and community-engaged research). Training and mentoring opportunities will also be available to community partners to ensure bi-directional learning and community engagement. Our clinical training program will focus on regions with limited maternal health care resources (e.g., maternity care deserts). Our Specific Aims are: Aim 1: Build content knowledge necessary for conducting maternal health research, related to: a) the maternal health crisis in the U.S.; b) foundations of community-engaged maternal health research; c) research design and methods; d) logistics of the research process. Trainees will have access to didactics to cover these topics, and a PRIHSM trainee discussion forum will enhance these learnings and build community. Aim 2: Enhance and evaluate mentored research experiences conducting rigorous, actionable maternal health research, by developing personalized plans and mentor teams tailored to the needs and interests of individual trainees. Trainees will work on specific PRIHSM Research Projects and have opportunities to work with community partners and other ongoing projects related to maternal health. Aim 3: Train clinicians in under-resourced settings on best practices for prevention, treatment, and management of PPH. We will work with Stanford’s GO MOMs program, which provides simulation-based training to optimize team performance in obstetric emergencies. In sum, through this Training Component, we will increase the pipeline of maternal health researchers, build competence in maternal health research and clinical care, and enhance community partnerships that will all contribute to our stated goals and enhance PRIHSM’s research projects. Together, accomplishment of these goals will lead toward a future of improved U.S. birth outcomes.